Multi-cohort study of factors that influence Alzheimer's disease biomarker and dementia timing

PROJECT SUMMARY/ABSTRACT
Advances in imaging and fluid-based biomarkers of Alzheimer’s disease (AD) including amyloid (A), tau (T) and
neurodegeneration (N), allow detection of underlying disease pathology decades before the onset of dementia.
Despite over a decade of AD biomarker research, the field still lacks the ability to accurately predict if and when
individuals with preclinical AD (those with biomarker detectable pathology in the absence of cognitive symptoms)
will experience dementia. Identifying factors that slow or quicken this preclinical timeframe is needed to improve
dementia risk prediction for preclinical AD patients and to inform optimal treatment windows for clinical trials
aiming to slow or prevent cognitive decline and impairment. Until recently, studying these factors was precluded
by observing different people for short periods of time that began studies in different disease stages with no way
to identify when disease began for individual participants. Our team developed and validated new methods that
provide individualized estimated amyloid onset age (EAOA) from amyloid biomarkers. EAOA can be used to
rearrange biomarker and clinical observations along an AD-specific timeline (i.e., an Amyloid Clock) anchored
to the start of preclinical AD. This project will apply this novel approach to existing data from that Washington
University Knight ADRC, the Wisconsin Alzheimer’s Disease Research Center, the Wisconsin Registry for
Alzheimer’s Prevention, the, the Mayo Clinic Study of Aging and the Alzheimer’s Disease Neuroimaging Initiative
to investigate factors across cohorts that influence the timing and trajectories of AD biomarkers and dementia.
This study was initiated based on our preliminary findings showing considerable differences between individuals
and cohorts regarding 1) when amyloid onset occurs, 2) the time between amyloid onset and dementia onset,
and 3) factors that affect AD biomarker and dementia trajectories in AD. In addition, studies from our center and
others have begun to link AD pathology, change in brain volume, and changes in cognition to social determinants
of health (SDoH) like neighborhood disadvantage. However, possible links between SDoH and the timing and
trajectories of AD biomarkers and dementia are not well-understood. Our hypothesis is that observed individual
and cohort differences in AD trajectories are due to a combination of demographic, environmental, sociocultural,
and biologic factors, and study design and sample composition. We will test this overall hypothesis in three
specific aims: 1) identify common factors across multiple cohorts that influence the timing and trajectories of ATN
biomarkers; 2) identify common factors across multiple cohorts that affect the time from amyloid onset to
dementia; and 3) explore inter-cohort differences in AD biomarker and dementia trajectories. This study will
leverage existing data in several well-characterized studies to provide new insights into mechanisms that explain
when preclinical AD begins and how long this preclinical phase lasts. This is expected to improve AD dementia
risk prediction for individuals and identify optimal windows for disease modifying and prevention therapies.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease is a growing public health crisis that has been difficult to study and to develop effective treatments due to a two-to-three-decade-long time between when abnormal proteins can be measured in the brain and the onset of disease symptoms that affect memory and thinking. This study will use a new concept to study Alzheimer’s disease brain changes and symptom progression based on a new statistical technique developed by the study PI that allows estimation of when the disease began utilizing a brain scan called positron emission tomography that measures abnormal buildup of a protein called beta-amyloid. Applying this new concept to data from multiple existing studies (>5,000 people) is expected to provide new information about the things that affect how fast the disease progresses, which will inform when patients with Alzheimer’s disease should be treated to have the greatest therapy benefits.